PROJECT 1

The rise in cancer incidence among younger adults (ages 20-39) in New York City (NYC) is currently outpacing the increase across the rest of the US (96.9 vs. 89.5 per 100,000). However, the burden of cancer in NYC is not equally distributed. In NYC's poorest neighborhoods, the rates of preventable cancers, such as cervical cancer, are 73% higher compared to the wealthiest neighborhoods. The magnitude of this disparity exceeds those associated with Black race, Hispanic ethnicity, or residence in a rural county documented in a previous population-based study of the US. Rather, it is likely the persistent poverty in these neighborhoods that drives cancer disparities. Despite these known facts, there remains limited research on multi-level and multi-generational approaches that address the impact of persistent poverty on youth and young adults' current and future cancer risk behaviors.

Effective cancer education interventions in schools could significantly impact health-promoting intentions and cancer risk behaviors in younger adults. To date, most school-based intervention studies have been limited. The need for this research is especially salient in NYC, the most populous city in the United States, with nearly 2 million New Yorkers under 18. In response to RFA-CA-22-015 Cancer Control Research in Persistent Poverty Areas, the CAncer Risk Education in Schools for YOUth (CARES4You) is a pragmatic cluster non-randomized controlled trial with pre- and post-measures, that will be implemented among 10 New York City middle schools (5 intervention vs 5 wait-list-control). CARES4You is a Next Generation Science Standards aligned curriculum, comprised of six-units (14 lessons) delivered over approximately 5 weeks in the standard science curriculum. The intervention is guided by the Self-Determination and youth empowerment theory; thus, it will leverage the natural desire of youth to be socially conscious, autonomous individuals who can be effective agents of social change. The intervention aims to: 1) increase students’ intention to engage in at least one health-promoting behavior (e.g., drink less or no sugary beverages) in the next month as a predictor of actual behavior change; and 2) increase cancer risk communication between the student and a caregiver. Additionally, we will explore the impact of increased cancer risk communication on the health-promoting behaviors of at least one adult caregiver in the household. Assessments of students will be conducted at baseline and after about six weeks. Caregivers will be assessed 6 weeks after implementation of the curricula. Process evaluation will assess program reach, adoption, implementation, maintenance, satisfaction, and perceived benefits by teachers and students over two years.

Public health relevance
A majority of the currently available critically appraised studies that implement a cancer educational intervention amongst school students provide minimal evidence to support the long-term effectiveness of these interventions on cancer knowledge, behavior, and intentions. As a result, this cluster-non-randomized wait-list control cancer educational trial will result in a multi-level and multi-generational intervention that addresses the impact of persistent poverty on youth and their respective family members' current and future cancer risk behaviors.